Multidimensional OCT Imaging Enabled by Compressed Sensing

Summary
Recent advances in the temporal speed and resolution of optical coherence tomography (OCT) imaging systems
have opened the door for new possibilities in time-lapse imaging of dynamic biological processes and imaging
samples with large surface area with micron scale resolution. Both spectral domain OCT (SD-OCT) and swept
source OCT (SS-OCT) systems frequently boast a-line rates well above 100 kHz and as high as 400 kHz. The
consequence of higher scan-rates is reduced motion artifacts and also higher data through-put. Modern
endoscopic OCT system are proposing scan-rates that result in data rates upwards of 1GB/s. This approaches
the data transfer rate and write speeds of modern PCs. Compressing this data at acquisition would have a
massive impact on these specific challenges. The kinds of tasks being tackled in OCT imaging increasingly
involve working with high-resolution datasets which could be multi-dimensional, where dimensions include space
(x,y,z), time, and contrast (polarization, elastography, phase sensitive, doppler). Compressed Sensing (CS)
provides tools for dealing with these massive datasets by sampling data far below the Nyquist limit to reduce
data through-put. Because of the potential of compressed sensing to reduce the required amount of data to
extract the necessary information within an image, compressed sensing has revolutionized magnetic resonance
imaging (MRI), accelerating data acquisition which results in shorted scan times and thus cost savings. There
have been initial demonstrations on the use of compressed sensing in OCT. It is our goal to develop a
comprehensive approach for CS-OCT that will allow for imaging samples with a variety of architecture. Recent
advances in OCT hardware have resulted in better image quality. However, combined with compressed sensing,
we believe the full power of OCT can be utilized within applications that require large field of view imaging or
imaging over long periods of time to assess therapeutic effects, dynamics, and perturbations to organ systems.
Our goal within this project is to utilize predictive coding to showcase that compressed sensing can be utilized
within cardiac samples that have diversity of tissue types, while yielding >75% compression rate. Within this
small grant R03 proposal, we aim to develop, test, and demonstrate a new approach for compressed sensing
OCT that can be utilized within images with cardiac imaging datasets. Our two aims include: 1) Compressed
sensing to enable large field of view volumetric 3D OCT imaging and 2) Impact of compressed sensing on
extracting tissue features and architecture.

Public health relevance
Project Narrative Recent advances in the temporal speed and resolution of optical coherence tomography (OCT) imaging systems have opened the door for new possibilities in time-lapse imaging of dynamic biological processes and imaging samples with large surface area with micron scale resolution. Compressing this data at acquisition would have a massive impact on data through-put and image acquisition time for multidimensional OCT imaging.